Mapping postnatal oxytocinergic system and offspring neurobehavior after induced birth with oxytocin

Project Summary/ Abstract
Exogenous oxytocin (OT) is widely used for the induction of labor in pregnant women. Though induction of labor
with OT confers many maternal and neonatal benefits, its use is not without adverse effects. Epidemiological
studies suggest an association between OT use and neurodevelopmental disorders, but they are conflicting and
do not provide mechanistic information. This knowledge gap is concerning because signaling through the OT
receptor (OTR) is critical for the establishment of social behavior in mammalian species. With the rising popularity
of elective induction of labor, where labor is induced for convenience and not for maternal or fetal indications, it
is important to comprehensively understand the impact of maternally administered OT on the developing brain.
Though OTR dysregulation in the developing brain has been suggested as a possible mechanism, mechanistic
studies are lacking because of the lack of a high-fidelity animal model that mimics labor management in pregnant
women. To address this, we successfully created and validated a pregnant rat model for labor induction by
continuously delivering an escalating dose of intravenous OT through a microprocessor-controlled precision
pump. In new preliminary studies, we adapted this high-fidelity model to mice with minor technical modifications
and confirmed that induced birth with OT was associated with a substantial decrease in OTR gene expression
in the neonatal mouse cortex. The fundamental objective of this proposal, therefore, is to chart the developmental
trajectory of OTR and OT expression in the postnatal brain after induced birth with OT. To accomplish this, we
will induce labor with OT in transgenic reporter mice (OTRvenus/+) and leverage the use of high-resolution brain-
wide imaging techniques (serial two-photon tomography and light sheet fluorescent microscopy imaging) to
comprehensively visualize the developing OTR-OT system in the postnatal brain (Aim 1). Motivated by our
observations of early communicative delay and impaired empathy-like behaviors in male rat offspring after
induced birth with OT, we will extend these behavioral studies to mice to enable mapping of dysregulated
behavior to brain-wide changes in the OTR-OT system (Aim 2).
Successful completion of these experiments will (i) provide a comprehensive perturbation map of how perinatal
OT exposure alters the developmental trajectory of the OTR-OT system, and (ii) delineate the neurobehavioral
impact of such perturbation. Because these studies are ethically inconceivable in human subjects, combining
our mouse model for labor induction with innovative whole brain imaging techniques provides unparalleled
opportunities to comprehensively answer this important question. Regardless of the outcome of our research,
our findings will have a significant impact — be it a paradigm shift in current dogma or providing scientific
reassurance to potential mothers.

Public health relevance
Project Narrative More than 30% of pregnant women receive oxytocin for induction of labor in the United States. Despite concern over an association between this practice and the risk of autism spectrum disorders (ASD), a thorough mechanistic understanding is currently lacking. Considering the importance of oxytocinergic signaling in ASD, this proposal will comprehensively investigate the impact of maternally administered oxytocin on the oxytocinergic system in the developing brain using a hi-fidelity pregnant mouse model for labor induction.